ESTROGEN OR ESTROGEN/PROGESTIN REPLACEMENT THERAPY ON GLUCLOSE/LIPID METABOLISM

Clinical trial evaluating varying estrogen replacement therapies (ERT) in post-menopausal diabetic women to test the hypothesis that ERT improves serum lipid levels, with little detrimental effect on glucose control.